PHASE I STUDY OF TOPOTECAN AND FIELD RADIATION FOR PONTINE GLIOMA OF CHILDHOOD

The hypothesis to be tested is that giving topotecan in combination with radiation will kill brainstem glioma cells better than topotecan alone and that children treated this way will have a better outcome. The purposes of this study are 1) to determine the highest dose of topotecan that can safely be given with radiation therapy to children with brainstem glioma; 2) to determine the side effects of this treatment; and 3) to determine whether this drug combination helps control the growth of brainstem glioma.